Integrating personal values into primary care for Veterans with multimorbidity

Background: Veterans with > 2 chronic conditions (multimorbidity) comprise almost 50% of patients in the
Veterans Health Administration (VA). Primary care providers (PCPs) provide over 90% of outpatient VA care for
the most complex, high-risk Veterans with multimorbidity. At present, these patients and their PCPs must juggle
numerous healthcare and psychosocial needs with limited time and resources, both in clinic and in self-
management at home. Patients and PCPs also make decisions about what care needs to prioritize without
adequate guidance from clinical practice guidelines, many of which focus on single-disease processes. Patients
and PCPs often disagree about what is most important; patients prioritize symptoms, while PCPs emphasize
prognosis. Studies suggest that helping patients and PCPs communicate about what is most meaningful in life
to patients (i.e., “personal values”) and align preferred health outcomes (i.e., “health priorities”) streamlines care,
lowers treatment burden, and reduces unwanted interventions. To date, no study has clarified the circumstances
in which personal values can guide health decisions or developed an approach linking personal values and
actionable clinical care that helps navigate tensions between conflicting priorities. To address these gaps, this
CDA will integrate a patient’s personal values into high-quality primary care by developing and testing an
intervention (“Vet-Align”), a values-based approach to care for higher-risk Veterans with multimorbidity.
Significance/Impact: This CDA advances VA and HSR&D priorities by improving patient-centric primary care
and addressing what matters most to Veterans. This has long-term implications, including improving the
specificity and personalization of VA quality metrics, advancing universal health outcomes, promoting patient
engagement and adherence in care, and reducing waste and harm from unwanted or inappropriate care.
Innovation: This CDA develops and tests a novel intervention using patient values and priorities to align primary
care planning and delivery. This CDA will advance multimorbidity care and draws on novel methods including
human-centered design (HCD) and multi-criteria decision analysis (MCDA), a participatory decision process.
Specific Aims: 1) Understand how and when Veterans with multimorbidity connect values, health, and
healthcare, to clarify the life and health circumstances where patient values directly influence PCP-patient care
planning and self-management decisions; 2) Examine how VA ambulatory quality metrics align with and support
patient priorities and values, to develop guidance for aligning disease-oriented quality metrics with patient-
centered priorities of Veterans within a personal values-based care delivery model; 3) Refine and pilot test the
acceptability and feasibility of Vet-Align, a values-based intervention for Veterans with multimorbidity, including
tools and workflows for VA primary care to translate patient values into actionable clinical care plans.
Methodology: Patients with > 2 chronic diseases at higher risk for adverse events are eligible for Aims 1 and 3.
Aim 1 uses 25-30 semi-structured patient interviews, analyzed with content analysis. Aim 2 uses MCDA to
combine healthcare expert perspectives and clinical evidence to rank outpatient VA quality metrics according to
a patient’s preferred health priority. Building from findings and products from prior Aims, Aim 3a develops a
novel, PCP-facing action-planning tool and workflows using HCD. Aim 3b pilot tests the tool in a clinical
intervention (Vet-Align) for 30-36 patients and 15-20 PCPs. Vet-Align includes staff skills training and patient
sessions with health coaches to elicit patient values, set health priorities, and personalize the action planning
tool to send to PCPs. Feasibility and acceptability will be assessed from patient and staff perspectives.
Next Steps/Implementation: The intervention developed in this CDA-2 will provide the foundation for a full
randomized clinical trial evaluating clinical effectiveness through change in patient-centered outcomes and care
quality, and testing implementation strategies for sustainment. Long term goals of this research trajectory are to
strengthen the patient-centeredness and quality of VA primary care for Veterans with multimorbidity.

Public health relevance
Patients with multiple chronic health conditions (i.e., multimorbidity) and their primary care providers (PCPs) must deal with numerous, often competing health concerns. With many competing health concerns, focusing healthcare on the outcomes patients prefer can help avoid burdensome, unwanted, or harmful care. This project develops an intervention (Vet-Align) to align what Veterans with multimorbidity find meaningful and their preferred health outcomes with the routine clinical care provided by PCPs. This study clarifies Veteran perspectives on how what is meaningful in life affects their health decisions, designs an evidence-informed tool and pathways to guide Veterans and PCPs in making health decisions consistent with Veteran-preferred health outcomes, and tests the intervention’s acceptability and feasibility for patients and staff at two VA primary care clinics. This research promotes a person-centered care approach for Veterans with multimorbidity by aligning care with what matters most to patients, with long-term potential to improve care quality and patient engagement.